MET kinase fusions in pediatric glioblastoma

ABSTRACT
High grade gliomas (HGGs), the most deadly malignant primary brain tumors in children, and are
incurable with current therapies. To find mutations that drive formation and progression of pediatric HGGs
(pHGGs), we genomically characterized over 25 tumors, and we identified fusion mutations in the MET and ALK
receptor tyrosine kinases. Recent comprehensive analyses show that RTK fusions are found in up to 40% of
pHGGs, and among the most common are MET and ALK fusions, found in more than 10% of pHGGs. Our and
others’ data show that for many RTK fusions, in which the C-terminal kinase domain is fused to N-terminal
regions of other proteins that are normally highly expressed in neuro-glial stem/progenitor cells, indicating that
MET fusions are likely overexpressed as a consequence of developmental programs. Our results show that RTK
fusions, such as the MET fusions, create constitutively active kinases capable of transforming neural stem cells
into pHGG-like tumors. FDA-approved small molecule tyrosine kinase inhibitors (TKIs) exist that penetrate the
blood-brain barrier that may benefit pHGG patients with MET and ALK fusions as well as other RTK fusions, and
these TKIs are being tested in patients with RTK fusions on an investigational basis. However, despite initial
responses, MET fusion pHGG patients quickly developed resistant secondary tumors. Therefore, we are using
our experiments MET fusion models, which include patient-derived pHGG tumor stem cells and xenografts as
well as immunocompetent pHGG mouse models, to discover TKI resistance mechanisms. Already, our
preliminary studies implicate cell-intrinsic innate immunity and inflammatory cytokine signaling in TKI drug
tolerance and emergence of resistance among pHGG cells with MET fusions. To discover and study resistance
mechanisms for MET and other RTK fusions in pHGG, we propose to two aims to 1) examine interactions
between RTK fusions, RTK kinase inhibitors, and inflammatory cytokine signaling pathways and their effectors
in vitro and in vivo in the brain using our robust MET fusion models, and to 2) test synergy between RTK kinase
inhibitors and inflammatory pathway inhibition using pharmacologic and genetic approaches. We will use
additional models of RTK fusions pHGGs to determine if our observations are generalizable among pHGGs with
RTK fusions. The results of our research may lead to development of new combination precision treatment
strategies for pHGG.

Public health relevance
PROJECT NARRATIVE High grade gliomas (HGGs), the most deadly malignant primary brain tumors in children, are resistant to current therapies. We have identified fusion mutations in the MET and ALK receptor tyrosine kinases (RTKs) associated with pediatric HGG (pHGG), and we propose to test the therapeutic efficacy of tyrosine kinase inhibitors combined with other therapeutic agents in experimental models of MET mutant pHGG. Our results could lead to new or improved strategies to targeted RTK mutant variants in pHGG.